Discovery of diabetes-relevant ÃÂ² cell enhancers through 4D enhancer mapping, integrative analysis, and large-scale CRISPRi perturbation screens

ABSTRACT
Enhancers are essential regulatory elements that together with transcription factors (TFs) instruct cell-
type specific transcriptional programs during development, tissue homeostasis and regeneration. Initiatives
such as the ENCODE project, revealed tens of thousands putative enhancers based on linear proximity, using
criteria like chromatin accessibility, TF binding, and histone modifications such as H3K27ac. However, a main
challenge of uncovering functional enhancers and assigning them to target genes lies in the complexity of the
3D chromatin organization, which can influence enhancer specificity and activity. Using an advanced
chromosome conformation capture assay, we recently captured the dynamic rewiring of 3D enhancer networks
during mouse somatic cell reprogramming and discovered multi-connected enhancers that we named “3D
enhancer hubs”. Here we extend the 3D mapping approach to human primary islets, and compare islets from
healthy and type 2 diabetes (T2D) donors to assemble a 4D atlas to capture the rewiring of 3D enhancer
network in disease progression. At the same time, we plan to compare the enhancer network in adult islets to
earlier stages of development by using human pluripotent stem cells (hPSCs) to generate early β cells and
their developmental precursors. Utilizing these 4D genomic data, we will computationally nominate core β-cell
specific enhancers relevant to β cell development, function, and T2D, and then interrogate these putative
enhancers through large-scale CRISPRi mediated perturbation screens using hPSC-β cells. Enhancers
identified from the screening effort will be further validated in an established human β cell line and primary
human islet β cells. This proposal addresses a critical gap in the 4DN initiative, that is how to translate 3D
genomics data into functional data with respect to gene expression in the context of human health. Successful
completion of our aims will establish a paradigm for the discovery and interrogation of functional enhancers
that instruct transcriptional programs specific to a cell type of interest, reveal unique insights into their
mechanisms of action, and identify enhancers with relevance to human development and disease. For
instance, uncovering functional enhancers could assist the identification of noncoding causal variants identified
in genome-wide association studies.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) This project will take an integrative approach involving generating a 4D atlas of regulatory interactions during both development and disease progressions, computationally nominating diabetes-relevant β cell enhancers through integrative analysis and discovering functional enhancers through large-scale perturbation screens. Knowledge gained from the study will provide a conceptual framework for dissecting gene regulatory networks that instruct the β cell fate and function during development and in diabetic conditions.